Advanced Preclinical Testing of a Broad-Spectrum Antiparasitic Quinolones for Veteran Health

VA scientists have discovered antiparasitic quinolones that are highly effective against malaria and
toxoplasmosis. Malaria is a potentially fatal infection that is a deployment hazard for veterans. The many
veterans who have HIV or who undergo hematopoietic stem cell or solid organ transplant are at risk of
developing Toxoplasma encephalitis when they are immunosuppressed. Current treatments for malaria and
prophylaxis for malaria are limited by the spread of drug resistance. Medicines for toxoplasmosis have high
rates of side effects that are more common and problematic in HIV and transplant patients. This proposal
builds on research that has identified ELQ-422 as a lead antiparasitic quinolone prodrug that is effective in
animal models of toxoplasmosis and malaria, and is not toxic in cellular assays and efficacy experiments. The
next step in preclinical testing is drug safety testing in animals. To achieve this, the maximum tolerated dose
and no observed adverse effect level of ELQ-422 will be determined in rats. Demonstrating an acceptable
therapeutic index of ELQ-422 in rats will allow for large animal testing and subsequent clinical trials. ELQ-422
is anticipated to be safe; however, identifying alternate antiparasitc quinolones is necessary in the event that
ELQ-422 does not have an acceptable therapeutic index. The alkoxy carbonate ester promoiety of ELQ-422
that increases ELQ bioavailability close to 4 times will be applied to ELQs that were potent but limited by
bioavailability. The promoiety will also be applied to a series of ELQ derivatives that will be synthesized to
optimize a recently discovered ELQ that is 100 times more potent than ELQ-316, which is the active
component of ELQ-422. These new prodrugs will be tested in a cascade of cellular and enzyme assays for
efficacy and toxicity followed by in vivo studies of efficacy and pharmacokinetics. Lead compounds from these
experiments will be evaluated for safety in rats in the same manner as ELQ-422. Finally, ELQ-422 and its
active component ELQ-316 have been found to be synergistic with atovaquone (ATV) in acute models of
toxoplasmosis and limit the development of drug-resistance in an animal model of human babesiosis, an
infection that is similar to malaria. The underlying mechanism of synergy will be examined by comparing the
cytocidal concentration and the concentration dependent kinetics of parasite inhibition of ELQ+ATV compared
to each compound alone. In addition, the pharamacokinetic effects of ELQs and ATV on each other will be
determined. The synergistic effect of ELQ+ATV will be tested in vivo as malaria prophylaxis and against latent
Toxoplasma gondii infection. Overall, the proposed research will advance new broad-spectrum antiparasitic
quinolones toward clinical evaluation and define treatment strategies that will enhance the clinical applicability
of antiparasitic quinolones.

Public health relevance
Better medicines for malaria and toxoplasmosis will improve veterans' health. Many veterans have been deployed to countries where malaria is common. Malaria can be fatal or cause long lasting kidney or brain damage. People who are immunosuppressed from HIV, or from organ or stem cell transplant are susceptible to brain infection caused by toxoplasmosis. The VA is the largest single provider of HIV care in the United States and has an active transplant program. Current drugs for malaria are limited by the spread of drug-resistant malaria. Drugs for toxoplasmosis have high rates of side effects. Through support from the VA, we have discovered new drugs that are remarkably effective in animals against both malaria and toxoplasmosis. We will test recently discovered drugs for efficacy and test the lead drug for safety in animals so that it can be advanced to human clinical trials. !! ! ! ! !